Point-of-care optical spectroscopy platform and novel ratio-metric algorithms for rapid and systematic functional characterization of biological models in vivo

PROJECT SUMMARY
Cellular metabolism is highly dynamic and strongly influenced by its local vascular microenvironment, gaining a
systems-level view of tumor metabolism and vasculature in vivo is essential in understanding many critical
cancer biology questions. However, there are surprisingly few techniques available that can quantify the key
metabolic and vascular endpoints together in vivo with easy access. The goal here is to fill this gap by
developing a point-of-care optical spectroscopy platform with a tumor-sensitive fiber probe and novel ratio-
metric data processing techniques to quantify the major axes of tumor metabolism (glucose uptake,
mitochondrial membrane potential, Bodipy) and the associated vasculature (oxygenation, hemoglobin) on
biological models in vivo. For scientific validation and translational purposes, we will compare our techniques
with existing metabolic tools, we will also integrate our optical strategies with the state-of-art metabolomics
technique, i.e. Stable Isotope-Resolved Metabolomics (SIRM), to provide a rapid and comprehensive
understanding in tumor metabolism. We will then demonstrate our synergistic approach through addressing a
contemporary problem in cancer therapy for head and neck squamous cell cancer (HNSCC). Specifically, we
will address the critical challenge of radio-resistance (RR) in HNSCC and test the hypothesis that radiotherapy
(RT) induced HIF-1α and HIF-2α activation and the following metabolic changes are responsible for HNSCC
RR and recurrence, the tumor-specific in vivo genetic editing platform targeting on HIF-1α and HIF-2α can
improve RT efficacy. Our point-of-care optical spectroscopy along with novel ratio-metric algorithms make our
technologies easy to access, easy to use, and systematic, which are all critical to maximizing its accessibility
for cancer research. Our spectroscopy techniques and their integration with the SIRM will provide new ways of
studying cancer biology and diseases, and they will also impact the study of a wide array of other biomedical
problems through the lens of tumor bioenergetics and vasculature. Our study on HNSCC RR mechanisms and
the demonstration of tumor-specific genetic editing platform in orthotropic HNSCC models will offer new ways
for targeted RT to improve HNSCC patient survival rates. The platforms and methodologies developed in this
project will be applicable to the study of RR and recurrence in other types of human cancers.

Public health relevance
PROJECT NARRATIVE The goal of this project is to establish novel optical strategies for rapid systematic metabolic characterization of biological models in vivo to address questions in the field of HNSCC radio-resistance and recurrence using orthotropic HNSCC models. We will also integrate our optical strategies with the state-of-art Stable Isotope- Resolved Metabolomics (SIRM) to provide rapid and comprehensive understanding in tumor metabolism that relates to radio-resistance. Our synergistic approach will provide the metabolic underpinnings of radio- resistance and recurrence and facilitate advances in the understanding of tumor biology, assessment of recurrence risk and design of therapies that can mitigate radio-resistance and recurrence altogether.